Development and Characterization of Peptidomimetic Small Molecule Activators of Peptidase Neurolysin for Stroke Therapy

SUMMARY
Current stroke research focuses more on understanding the brain’s self-protective and repair mechanisms. Detailed
elucidation of these mechanisms is crucial as such knowledge could lead to development of therapeutic interventions which
mimic or engage the brain’s self-protective/repair mechanisms and can lead to successful stroke therapy. With the proposed
research we seek to develop potent and selective ‘drug-like’ small molecule activators of peptidase neurolysin (Nln) which
will be used as research tools and lead chemical entities to move the drug discovery process forward for development of a
novel class of drugs. Recently published and pilot studies from our laboratory have identified Nln as one of the brain’s self-
protective mechanisms, functioning towards preservation and recovery of the brain after stroke. Functional significance of
Nln in the post-stroke brain is based on its ability to inactivate several neurotoxic and generate three cerebro-
protective/regenerative neuropeptides, which are known from numerous experimental and clinical studies to critically
contribute to the outcome of stroke. Based on this evidence we view Nln as a central peptidase involved in brain restorative
mechanisms following stroke. In this collaborative application we will leverage our expertise in multiple aspects of the drug
discovery process and will develop potent ‘drug-like’ small molecules which can selectively enhance the catalytic efficiency
of Nln and can be used as experimental therapeutic agents for post-stroke brain protection and recovery. This proposal has
been formulated based on our compelling experimental data indicating that catalytic activity of Nln can be enhanced by two
structurally related dipeptides and a distinct non-peptide chemotype. Feasibility of the proposed studies is shown by our
initial structure-activity relationship studies of the identified Nln activators and by in vivo experiments in two different
mouse stroke models indicating that inhibition of endogenous Nln after stroke aggravates stroke injury, whereas
overexpression of Nln in the brain or its delivery to the post-stroke brain substantially improves stroke outcome. The goals
of this proposal will be accomplished in three well-integrated aims: (1) design and characterize a diverse and proprietary
library of compounds based on three active hits and guided bioassays to identify critical functional residue interactions
within the Nln binding site, and to develop high-potency, brain-permeable, selective activators of Nln with ‘drug-like’
properties; (2) conduct biochemical and structural studies to characterize the activation mechanism that the identified Nln
activators exploit; (3) determine the therapeutic potential of Nln activators in post-stroke brain protection and recovery using
a mouse model of stroke. This work is highly innovative because there are no activators of Nln described in the scientific
literature and such compounds were never considered to have therapeutic potential. The collaborative investigative team,
comprising experts in medicinal chemistry and drug discovery, crystallography and structural biology, enzyme biochemistry
and pharmacology, blood-brain barrier physiology and stroke pharmacology, is highly qualified to conduct the proposed
studies. Our long-term goal is to translate the lead Nln activators from bench to bedside and develop an effective therapy,
which would transform the current treatment modalities for a vast number of stroke patients.

Public health relevance
NARRATIVE Stroke is a leading cause of death and long term disability in the U.S. with an unmet need for efficacious treatments that can be utilized in a large number of patients. In this proposal we plan to develop potent and selective ‘drug-like’ small molecule activators of peptidase neurolysin (Nln) which will be used as research tools and lead chemical entities to move the drug discovery process forward for treatment of human ischemic stroke. In addition, the knowledge about the molecu- lar mechanism(s) governing activation of this peptidase by small molecules and the design of potent and selective ‘drug- like’ small molecule activators of Nln could be translated to other peptidases and enzymes, activation of which bears ther- apeutic potential.